IN-VIVO AIRWAY CHANGES MEDIATED BY TRPV4

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. We will scan Trpv4 null mice and wild-type control mice exposed to diesel exhaust particles (DEP). The genetically modified mice will come from Dr. Liedtke's lab, where they will also be instilled with DEP.